Academic Training in Therapeutic Advancement for Child Health (ATTACH)

While tremendous advances in pharmacotherapy for adults have been achieved in recent years, expanding the
benefits of these new therapies to infants and children remains a significant challenge. Important developmental
changes in pharmacokinetics, pharmacodynamics, disease presentation and progression all impede direct
translation of adult therapeutics into pediatrics. The discipline of pediatric clinical pharmacology provides
necessary training in developmental physiology to leverage existing knowledge and guide rational therapeutics
for infants and children. However, the current pool of pharmacologists and pediatric sub-specialists with formal
training in clinical pharmacology is both small and aging. Additional pediatric clinician-scientists with training in
clinical pharmacology are urgently needed to ensure that therapies are optimized for infants and children. In
2015, under the leadership of Edmund Capparelli, PharmD (expert in pediatric pharmacokinetic (PK) modeling)
and Adriana Tremoulet, MD, MAS (expert in pediatric clinical trials), training in pediatric clinical pharmacology at
UC San Diego was formalized as a NICHD-supported T32 Training Program. We are proud of this first iteration
of a formal program to provide cutting-edge research training in pediatric clinical pharmacology. We now propose
a renewal of our T32 pediatric clinical pharmacology training program, entitled “Academic Training in Therapeutic
Advancement for Child Health” (ATTACH). In this renewal, we proudly seek to (1) modernize our program with
new program leadership, (2) recruit more world-renowned faculty to teach our fellows state-of-the-art
technologies, (3) launch a systematic tool to assess performance of our program and assist in program
improvement, (4) emphasize trainee and faculty mentor training, and (5) enhance recruitment methods to attract
a more diverse pool of applicants and trainees to stimulate diversity in the workforce. Our key objectives of the
first cycle of our training program will remain the same: (1) To increase the number Pediatric clinical
pharmacologists and Clinician-Scientists engaged in clinical pharmacology research as applied to child health;
(2) to attract outstanding young pediatric clinicians to UCSD and to expand their translational capacity through
clinical pharmacology methods; (3) to facilitate career development of ATTACH trainees under the guidance of
world class, established investigator-faculty mentors; and (4) to cultivate the early careers of women and minority
investigators in pediatric therapeutics. With our impressive group of mentors with outstanding training track
records, UCSD ATTACH Fellows will be poised to be tomorrow's leaders in pediatric clinical pharmacology.

Public health relevance
The proposed program is relevant to public health because training in pediatric clinical pharmacology is key to studying therapies for children and increasing the number of medications that are available for children. Fellows in this training program entitled “Academic Training in Therapeutic Advancement for Child Health” will receive state-of-the-art training in a strong mentorship environment in a broad range of important topics that are central to pediatric clinical pharmacology. Thus, the proposed training program is in line with NICHD's Strategic Plan as this program will train clinician-scientists the skills needed to excel within the field of pediatric clinical pharmacology and thus “enhance the lives of children and adolescents”.